Anti-tumor and autoimmunity signatures in Down syndrome

Summary/Abstract
This is a request for an Administrative Supplement for the INCLUDE Project for R01 CA231226 “Defining the
features of T cell response to tumor and self-antigens as predictors of response to checkpoint therapy”. The
proposed studies for the Administrative Supplement are within the scope of the active parent grant, focused on
Down syndrome (DS) and address two of the three components prioritized by the INCLUDE Project
(Component 1: Targeted high risk – high reward basic science studies highly relevant to DS and Component 2
Assembly of a large cohort of individuals with DS across the lifespan to perform deep phenotyping and study
co-existing conditions. Our objectives are: 1) To define an optimal anti-tumor signature by characterizing the
immune landscape in individuals with DS with co-occurring autoimmune disease and then comparing to the
immune landscape in patients with solid tumors who develop irAE after immune checkpoint inhibitor (ICI)
therapy in order to identify an optimal anti-tumor signature (Component 1); and 2) Expand our existing DS
biorepository to include more adults and more individuals with co-occurring autoimmune disease (Component
2). The central hypothesis for the proposed studies is that the immune features in DS that promote
autoimmunity are the same immune features that protect from solid tumors and promote therapeutic response
to ICI therapy. It is based on 1) observations that people with DS are protected from developing solid tumors
and also predisposed to autoimmunity; and 2) Growing evidence of an association between therapeutic
response to ICI therapy and development of autoimmune irAEs. The goal of Aim 1 is to increase both the
number of adults and the number of individuals with co-occurring autoimmune disease in our existing
biorepository. The goal of Aim 2 is to define an optimal anti-tumor signature by identifying shared
characteristics of the immune architecture between people with DS and those treated with ICI who develop an
irAE. These studies will determine the global immune landscape and antigen-specific T cell responses in
individuals with DS and co-occurring autoimmune thyroid disease and then compare to cancer patients who
develop ICI induced-autoimmune thyroiditis. The global immune landscape will be characterized using mass
cytometry and RNA-sequencing. Antigen-specific T cell frequency and phenotype will be determined using
activation-induced assays and single cell Cellular Indexing of Transcriptomes and Epitopes by Sequencing
(scCITE-seq). The proposed work will extend understanding of anti-tumor mechanisms and thus improve ICI
outcomes and elucidate potential ways to mitigate autoimmunity in people with DS without diminishing anti-
tumor effect. Importantly, it is within the scope of the parent award as it focuses on understanding T cell
responses in individuals that develop irAEs after ICI therapy. It also leverages the expertise and resources
already in place in the parent grant and utilizes the same approach and experimental design as the parent
grant to assess the global immune landscape and antigen-specific T cells.

Public health relevance
Narrative The proposed research is relevant to public health because it investigates why individuals with Down syndrome are at increased risk for autoimmune disease yet are protected from development of solid tumors. It will advance our understanding of anti-tumor mechanisms and thus provide insight into how to improve cancer immunotherapy. This knowledge will also be important for developing therapeutic approaches to treat autoimmune disease in Down syndrome.